Understanding the effects of dietary interventions on pancreatic ductal adenocarcinoma therapy cancer

Project Summary/Abstract
Pancreatic ductal adenocarcinoma (PDAC) is a highly aggressive cancer with limited treatment options
that has a five-year survival rate of <10%. PDAC progression is associated with dysregulated tumor and whole-
body metabolism that impacts therapy and quality of life, which has motivated research on how to best exploit
metabolic dependencies in PDAC for better cancer treatment. Nutrient utilization by cancer cells is regulated in
part by the availability of metabolites in the environment, and the PDAC tumor microenvironment in particular is
highly desmoplastic, consisting of stromal cells, extracellular matrix, and nutrient-poor interstitial fluid. These
microenvironmental factors can impact therapy response, suggesting that the efficacies of metabolism-targeted
drugs can be improved by manipulating components of the PDAC tumor microenvironment. One determinant of
metabolite levels in the tumor microenvironment is diet, and how diet affects cancer progression and treatment
is an important question for many patients. Since dietary recommendations to patients must be made in the
context of therapies being received, the value of any dietary intervention likely lies in its ability to enhance tumor
responses to cancer therapies. Understanding the molecular mechanisms that drive synergistic interactions
between diet and cancer therapies is critical for the translation of dietary recommendations into patient care.
The main objective of this proposal is to identify dietary interventions that synergize with cancer therapies
to impair PDAC progression. Mouse PDAC models will be used to examine how different diets enhance the
efficacies of standard-of-care FOLFIRINOX chemotherapy (Aim 1), lipid metabolism inhibitors in development
for cancer treatment (Aim 2), and inducers of ferroptosis, a non-apoptotic form of cell death being explored for
PDAC treatment (Aim 3). Mass spectrometry-based metabolomics and lipidomics, stable isotope nutrient tracing,
and RNA sequencing will be used to determine how diet-mediated changes to nutrient levels in the tumor
microenvironment alter the metabolism of PDAC tumors to shape their responses to these therapies. Elucidating
the metabolic mechanisms that underlie synergistic diet-drug combinations will provide scientific evidence that
can benefit patients with guidance on how to best incorporate diet and nutrition into cancer therapy.
The proposed training plan will help me transition into an independent academic position. A team of
outstanding scientists will mentor me to help me achieve this goal: Dr. Tyler Jacks, a leader in mouse cancer
models; Dr. Omer Yilmaz, a leader in dietary effects on cancer progression; Dr. Caroline Lewis, a leader in mass
spectrometry-based metabolomics and lipidomics technologies; and Dr. Brian Wolpin, a leader in PDAC
epidemiology. My training plan also outlines activities that will help me cultivate mentors, improve my scientific
skillset, improve science communication skills, develop teaching and mentoring skills, build my network, and
learn lab management skills. Together, the research proposal and career development plan will provide me with
the expertise needed to become a successful independent investigator and educator in the cancer biology field.

Public health relevance
Project Narrative Pancreatic ductal adenocarcinoma (PDAC) is a highly aggressive cancer that is associated with dysregulated tumor and whole-body metabolism that impacts therapy and quality of life. An opportunity for better exploiting metabolic vulnerabilities in PDAC for cancer treatment is to systematically examine how dietary interventions impact PDAC progression, therapy responses, and survival. This proposed research will elucidate the metabolic mechanisms underlying potential synergies between dietary factors and standard-of-care or emerging PDAC therapies in an effort to provide scientific evidence that can benefit patients with guidance on how to best incorporate diet and nutrition into PDAC treatment.